Telomere end processing and telomere stability maintenance in trypanosomes

Project Summary
Telomere, the protein/DNA complex at the chromosome end, is essential for keeping eukaryotic cells
proliferative. Conventional DNA polymerases cannot fully replicate the linear DNA ends, and most eukaryotes
use telomerase to synthesize the telomere G-rich strand de novo. The terminal telomere G-rich 3’ overhang
(G3OH) is essential for telomerase-mediated G-strand synthesis and formation of the T-loop structure that is
critical for protection of the natural chromosome ends from illegitimate DNA processes. In addition, the length of
G3OH needs to be regulated in order to avoid excessive telomeric recombination. Generation of the telomere
G3OH involves resection of the telomere 5’ end by exonucleases after the conventional DNA replication, G-
strand synthesis by telomerase, and C-strand filled-in. In higher eukaryotes, these telomere end processes are
regulated by OB fold-containing telomere ssDNA-binding proteins, which are absent in the kinetoplastid parasite
Trypanosoma brucei. Rather, we have found that T. brucei PolIE, a telomere protein and an A family DNA
polymerase, suppresses telomerase-mediated G-strand extension, helps ensure proper telomere C-strand
synthesis, and suppresses telomeric recombination. T. brucei causes sleeping sickness in humans and regularly
switches its major surface antigen, VSG, to achieve immune evasion. VSGs are monoallelically expressed
exclusively from loci immediately upstream of the telomere. We have shown that telomere proteins not only are
essential for T. brucei cell proliferation but also regulate VSG monoallelic expression and switching. However,
other than the fact that telomerase can synthesize the telomere G-strand DNA, mechanisms of telomere end
processing and its regulation are poorly understood in T. brucei. In this project, we aim to investigate
mechanisms of T. brucei telomere end processing regulation and telomere stability maintenance. In Aim
1, we will investigate how PolIE suppresses the telomerase action and whether it also affects the ending
nucleotides of the two telomere strands. The telomere C-strand fill-in in T. brucei presumably requires a DNA
polymerase. Since PolIE is a DNA polymerase, in Aim 2.1, we will test whether its DNA polymerase domain is
critical for its role in telomere end processing regulation. We have also identified Primase-Polymerase-like
protein 2 (PPL2, with a translesion DNA synthesis activity) as a telomere protein and found that PPL2 depletion
dramatically elongates the telomere G3OH length. In Aim 2.2, we will investigate whether PPL2 is important for
telomere C-strand fill-in and whether this function is PolIE-dependent. T. brucei does not have the non-
homologous end joining (NHEJ) machinery, while dysfunctional telomeres are frequently fused through NHEJ in
higher eukaryotes. In Aim 3, we will investigate whether homologous recombination and Microhomology-
mediated end joining are major pathways for telomeric recombination in WT and PolIE-depleted cells, which will
help reveal illegitimate processes that threaten the natural chromosome ends in T. brucei. Our studies will help
us better understand the telomere protein evolution and contribute to future development of anti-parasite agents.

Public health relevance
Project Narrative Telomere proteins are not only essential for genome integrity and cell proliferation in a kinetoplastid parasite Trypanosoma brucei but also regulate antigenic variation, a key pathogenesis mechanism enabling T. brucei to establish a long-term infection. Importantly, T. brucei uses PolIE, a novel telomere protein and an A family DNA polymerase, to coordinate telomere G- and C-strand DNA syntheses, which is completely different from that in higher eukaryotes where OB fold-containing telomere ssDNA binding factors regulate the telomere end processing. In this project, we will investigate the mechanisms of T. brucei telomere end processing and its regulation, which will not only greatly improve our understanding about telomere protein evolution but also contribute to future development of anti-parasite agents.